PHENYLALANINE METABOLISM IN HUMANS

Assess the effects of two levels of dietary phenylalanine (Phe) intake on the activity of liver Phe hydroxylase, measured in vivo in humans using stable isotope tracers.